Inflammation-induced cellular plasticity in pancreatic homeostasis and tumorigenesis

PROJECT SUMMARY
Pancreatic cancer is a near universally fatal disease with a 5-year survival rate of less than 9%. As the third
leading cause of cancer-related deaths in the United States, pancreatic cancer is a major public health concern,
necessitating significant advances in our understanding of the underlying disease etiologies. Substantial
evidence has recognized inflammation’s role in destabilizing tissue homeostasis. In the pancreas, inflammation
manifests as a transient cell-fate transition known as acinar-to-ductal metaplasia (ADM), which is known to play
varying roles in both tumor initiation and progression. However, much is still to be learned about how ADM and
inflammation—even after subsequent resolution—can lead to the accumulation of molecular changes that aid in
pancreatic cancer initiation. Interestingly, we have found that following pancreatitis, acinar cells carry chromatin
accessibility changes that persist even eighteen-weeks after histologic recovery. Furthermore, we observe that
following resolution of pancreatitis, the persisting inflammatory memory synergizes with either a secondary, sub-
threshold non-inflammatory stimulus or oncogenic stress to induce either promiscuous ADM induction or
pancreatic tumorigenesis, respectively. Acinar cells thus fail to fully differentiate, and maintain a ‘memory’ of the
cycle of metaplasia and regeneration, lowering the threshold for dedifferentiation and tumorigenesis. Motif
analysis demonstrates the enrichment of AP-1 motifs at these memory regions—a transcriptional effector
activated downstream of the Ras/MAPK pathway. In addition, our preliminary data demonstrates that the acinar
population responds heterogeneously to inflammation-associated injury—with both an ADM-permissive and an
ADM-resistant population co-occurring during pancreatitis. Given these findings, we hypothesize that AP-
1/Fra1 promotes inflammatory memory formation and tumorigenesis in a subset of pancreatic acinar
cells permissive to metaplastic transition. In the proposed studies, we set out to determine if AP-1/Fra1 is
responsible for memory formation, promiscuous ADM induction, and tumor initiation. Additionally, the proposed
studies serve to identify the cellular dynamics associated with metaplastic transition, the distribution of the
memory in ADM-permissive and -resistant populations, as well as the increased susceptibility of ADM-permissive
cells to malignant transformation. To address the functional role of Fra1, we will utilize complementary 2D/3D in
vitro systems and in vivo models of Fra1 deletion and AP-1 inhibition. To determine the molecular characteristics,
dynamics, and tumorigenic outcomes associated with the divergent cell fate decisions, we will employ distinct
lineage tracing mouse models that conditionally mark cells and reversibly induce mutant Kras in the pancreas.
We anticipate that a better understanding of these processes will further elaborate on the connection between
inflammation and oncogenesis, as well as provide avenues for the development of therapeutics that mitigate the
effects of these cancer-sensitizing states in high-risk patient populations with prior pancreatitis.

Public health relevance
PROJECT NARRATIVE Inflammation has a prominent role in tissue homeostasis and disease pathogenesis. Understanding the impact of pancreatitis on the establishment of a cancer-priming chromatin state – even after subsequent resolution – would yield novel insights into how healthy pancreatic tissue can accumulate epigenetic changes that ultimately aid in the growth of tumors. Our goal is to identify the molecules and mechanisms mediating this progression with the intent of designing therapies that limit tumorigenesis by erasing the cancer-sensitizing epigenetic memory in high-risk patient populations with a history of pancreatitis.